INTRAVENOUS ADMINISTRATION OF 14C LOSOXANTRONE (DUP941) FOR SOLID TUMORS

This is an open-label multiple dose study in which patients with advanced solid tumors will receive a single dose of losoxantrone as 14C-labeled compound during their first course of treatment. Blood, urine, and feces will be collected for analysis. Following enrollment, patients will receive up to 8 courses of losoxantrone, once every 3 weeks, depending on response to treatment and tolerability.